Bioinformatics Core

MISSISSIPPI INBRE
BIOINFORMATICS CORE
Project Summary/Abstract
With advancements in biomedical research, integration of bioinformatics has become a critical component to
understanding complex interactions of multiple genes. The mission of the Bioinformatics Core is to provide a
robust bioinformatics network to advance biomedical research and training infrastructure in Mississippi. This
network builds on infrastructure we have established in the current phase. The bioinformatics experts that
make up the network are dedicated to enhancing the biomedical research capacity in the state and training
students and faculty in bioinformatics tools. The Bioinformatics Core is committed to: 1) providing
bioinformatics support for all MS investigators including all IDeA programs; 2) enhance and maintain
bioinformatics infrastructure; 3) developing and implementing data management systems; and 4) providing
education and training for students and faculty. The Bioinformatics Core will continue to work closely with the
Proteomics and Genomics Core Facilities, which are integrated within the Instrumentation and Services Core,
to provide expertise to investigators in analyzing complex datasets. Critical services provided by the Core are
access to commercial software, computational environments, and training, which includes curriculum
development. The Core is vital to MS INBRE's mission to enhance the competitiveness of biomedical research
and modernize science education in MS. The following aims were developed to accomplish the mission of the
core and complement the MS INBRE program: 1) To provide bioinformatics support for MS investigators; 2) To
develop, implement, and maintain a data management system for MS investigators; 3) To provide education
and training in bioinformatics tools for students and faculty. At the completion of this project, we expect have
enhanced the quality of bioinformatics resources in the state and to have positively impacted biomedical
projects for MS investigators particularly at undergraduate institutions.